A Longitudinal Mixed Methods Study of Psychosocial and Behavioral Health After Non-Fatal Firearm Injuries Among High-Risk Youth

ABSTRACT
Far more youth survive firearm injuries than die, yet their psychosocial and behavioral health outcomes are understudied. These outcomes may lead to poor mental health, risky behaviors (e.g., substance use, aggression, impulsivity), recurrent violence victimization, and reduced prospects for economic mobility in adulthood. The research aims of this proposal are to (1) identify the psychosocial and behavioral health sequela among adolescents and young adults through one year after experiencing an interpersonal firearm injury, and (2) evaluate the existence of participant groupings who share similar psychosocial behavioral outcomes, firearm propensity (access, ownership, carriage, attitudes), risk of repeat victimization, and economic prospects in young adulthood. Given that youth and persons of color are disproportionately affected by firearm violence, the variables within this study are informed by the National Institute on Minority Health and Health Disparities Research Framework and Social Cognitive Theory. Knowledge derived at six-month intervals after being discharged from a Level 1 Trauma Center will elucidate individual, interpersonal, and environmental influences on health outcomes and the risk for additional violence victimization. This K23 Award provides research experience, mentorship, and advanced statistical and mixed methods training to foster an independent research career focused on providing the foundation to inform, refine, and evaluate hospital-based violence intervention programs.

Public health relevance
Public Health Relevance Statement Adolescents and young adults who survive a non-fatal firearm injury may risk revictimization, the adoption or increase of firearm-related behaviors, poor mental health, and reduced economic mobility. Due to the perpetuating use of firearms in communities and the dearth of knowledge regarding firearm injury survivorship, it is imperative to understand the long-term impact of injury to psychosocial and behavioral health. We will identify risk and protective factors for repeat victimization and increased firearm-related behaviors, and we will explore the characteristics of patient subgroups to facilitate the effectiveness and efficiency of hospital-based violence intervention strategies.